Phosphatidylserine acyl chain remodeling regulates KRAS spatial distribution and function on the plasma membrane.

Project Summary:
KRAS small GTPase activates mitogen-activated protein kinases (MAPKs) and participates in cell proliferation.
KRAS is one of the most mutated proteins in cancer, with its mutations found in 98% of pancreatic tumors, 45%
of colorectal tumors and 31% of lung tumors. Despite decades of intense focus, we still do not have any effective
means of inhibiting KRAS oncogenesis. KRAS function is mostly compartmentalized to the cell plasma
membrane (PM), where KRAS interacts with a select set of lipids to form signaling nanoclusters for effector
recruitment and signal transduction. We recently showed that KRAS nanoclusters are specifically enriched with
the mixed-chain phosphatidylserine (PS) species. In consequence, KRAS nanoclustering and effector binding
occur selectively in the presence of the mixed-chain PS. Thus, KRAS function depends on PS acyl chain
structures. We, here, propose to modulate PS acyl chains using lysophosphatidylcholine acyltransferases
(LPCATs). In particular, we now show that increasing LPCAT1 levels reduces major mixed-chain PS species in
human pancreatic tumor cells, and disrupts the nanoclustering of KRAS on the PM. This is further supported by
cancer patient data showing that patients with KRAS-dependent pancreatic or lung cancer contain lower levels
of LPCAT1. Another LPCAT member, LPCAT4, elevates the mixed-chain lipids and has been shown to promote
KRAS oncogenesis in patients. We hypothesize that, by shifting the proportions of the mixed-chain PS
species, LPCAT1 and LPCAT4 modulate KRAS nanoclustering and function. A successful testing of our
hypothesis may provide an alternative strategy for perturbing KRAS pathology for patients with KRAS-dependent
tumors. Our hypothesis is based on a well-established premise: KRAS nanoclustering and function selectiveluy
depend on the mixed-chain PS species, whose abundance is modulated by LPCAT1/4. To test our hypothesis,
we propose 3 Specific Aims. In Aim 1, we will examine a correlation between LPCAT1/4-altered lipidomics in
whole-cell, the PM and endomembrane with effects of LPCAT1/4 on PM properties critical to KRAS function. In
Aim 2, we will examine a molecular mechanism, by which LPCAT1/4 regulate spatial distribution of KRAS,
potentially via remodeling PS acyl chains. In Aim 3, we will examine a molecular mechanism for how LPCAT1/4
modulate KRAS function in a cohort of mammalian and human tumor lines, as well as in vivo Caenorhabditis
elegans (established model system for studying KRAS oncogenesis). Here, we propose to rigorously examine a
novel mechanism, whereby remodeling PS acyl chain profiles by LPCATs modulates KRAS spatiotemporal
organization, signaling and function. We aim to test LPCATs as novel regulators of KRAS oncogenesis.
Biologically, although lipid acyl chains contribute to various important lipid bilayer properties, the importance of
acyl chains in cells, which typically contain thousands of lipid species, has not been well-understood. Our
proposed mechanism will contribute to our understanding of the potential biological roles of lipid acyl chain.

Public health relevance
Project Narrative: Plasma membrane-anchored KRAS small GTPase selectively interacts with distinct phosphatidylserine (PS) species with mixed-chain acyl chains in the regulation of cell proliferation of normal or tumor cells. We propose to investigate how remodeling PS acyl chain profile, by lysophosphatidylcholine acyltransferase 1 (LPCAT1) and LPCAT4, modulates KRAS nanoclustering and function. Because of the key roles of KRAS in human cancer, our new findings allow us to better appreciate how lipid acyl chain profile contributes to cancer biology.